Pharmacoequity Conference

Project Summary/Abstract
The University of Pittsburgh Center for Pharmaceutical Policy and Prescribing (CP3) is
requesting an AHRQ Conference Grant to support the 3rd Annual Pharmacoequity Conference.
The conference will feature presentations centered on key research findings, new
methodologies, and policy solutions that utilize and apply pharmacoequity principles to ensure
the equitable access to pharmacotherapy to all persons, referred to as “pharmacoequity”. This
conference provides a unique platform for which engaged stakeholders from payer groups,
health systems, and research communities can gain insight on how to address and apply
pharmacoequity principles and tools within their respective fields. The first two CP3
Pharmacoequity Conferences were held in 2022 and 2023 to extremely positive reception, with
93% of survey respondents rating their post-conference understanding of pharmacoequity as
good or very good.
We want to continue to grow the conference and to expand our impact for the 2024 conference.
The pharmacoequity conferences define pharmacoequity in a variety of settings, address
research and policy issues related to pharmacoequity, facilitate networking and information
exchange among individuals across disciplines, and educate attendees about applying
principles of pharmacoequity to their own work. For the 2024 conference, CP3 will once again
convene a diverse panel of national experts to share their expertise and to engage attendees in
dialogue about the state of pharmacoequity in the United States and pathways to achieve it.
Specific aims are to:
1. Summarize, exchange, and disseminate novel research findings pertaining to the
application and utilization of pharmacoequity principles in research and policy.
2. Identify key priorities for action to improve pharmacoequity outcomes through research
and policy.
3. Catalyze networking and career development for individuals interested in advancing
pharmacoequity, with a particular focus on those from underrepresented backgrounds.

Public health relevance
Pharmacoequity, a term coined by researchers within our Center for Pharmaceutical Policy and Prescribing (CP3), refers to the goal of ensuring that all individuals, regardless of race/ethnicity, socioeconomic status, or availability of resources, have access to the highest quality medications required to manage their health needs. The proposed 3rd Annual Pharmacoequity Conference will feature presentations centered on key research findings, new methodologies, and policy solutions that utilize and apply pharmacoequity principles to ensure the equitable access to pharmacotherapy to all persons. This conference provides a unique platform for which engaged stakeholders from payer groups, health systems, and research communities can gain insight on how to address and apply pharmacoequity principles and tools within their respective fields.